Midcareer investigator award in patient-oriented research in the area of perinatal-developmental neuroscience

Despite evidence that 1 in 5 children are at risk for psychiatric disorders, only 1 in 20 young children receive
mental health care. Thus, a high number of children who would benefit from mental health care remain untreated.
My long-term goal is to improve brain-based targets for early detection and behavioral interventions of childhood
psychiatric disorders. The area of perinatal-developmental neuroscience (PDN) is of high public health
significance as a substantial proportion of pregnant women will experience health, environmental, or
psychological stressors, which have early and long-lasting effects on offspring. Increasing the number of
research programs that can support training in PDN is paramount. The K24 will allow me to: 1) expand my
expertise in advanced analytic methods to support trainee research, and 2) establish an internationally
recognized research and training program focused on fetal-infant brain and behavioral origins of mental health.
My K24 training program, the Columbia Engagement, Stability, and Success in PDN will provide an individualized
approach to research training: assessing the research skills and career goals of mentees early on and developing
personalized training modules; didactics; experiential, hands-on training; and research productivity that follow
their individualized plan. The program also includes a monthly seminar series alternating between science and
career-networking topics. Our prior studies suggest there may be common biological pathways by which early
exposures exert their influence on offspring conferring psychiatric risk – with recent attention to the immune
system and/or hypothalamic-pituitary-adrenal axis, and brain regions involved in behavioral regulation. Using the
expanded analytic skills obtained through this K24, my mentees and I will conduct studies to examine whether
four key prenatal exposures: maternal depression, body mass index, infection, and blood glucose are associated
with connectivity and morphology of brain regions (e.g., dorsal anterior cingulate) involved in behavioral
regulation. In a subset of the cohort, we will also consider the potential mediating effects of inflammation and
glucocorticosteriods. I have a unique opportunity to pool data from cohorts of pregnant women-fetal dyads
involved in research studies (2004 to present; n~500) at Columbia University Irving Medical Center – a large
center with a diverse patient population – and perform new data collection harnessing health information
technology (e.g., electronic medical records). The data set will serve as a platform for my mentees to produce
pilot projects and manuscripts, and practical experience conducting a project in an area of PDN that matches
his/her career goals within the scope of this funding mechanism. My strong commitment to and ongoing research
in patient-oriented research focused on identifying early antecedents of psychiatric risk, individualized
mentorship plans, direct involvement of mentees in the conduct of research, and tailored career development
program at Columbia University Irving Medical Center are strengths of this application. The K24 mentees will be
uniquely positioned to discover neurobiological and behavioral pathways associated with risk.

Public health relevance
Only 5% of young children receive mental health care, as most do not exhibit obvious psychiatric behavioral symptoms before age 2 or, more commonly, school age. The overall goals of this program are to 1) identify common biological and brain-based pathways by which prenatal exposures exert their influence on offspring and confer psychiatric risk; and 2) to train the next generation of patient-oriented scientists interested in perinatal- developmental neuroscience.